Comprehensive analysis of periocular mesenchyme composition, specification and function during anterior segment formation

PROJECT SUMMARY:

Inherited congenital anterior segment dysgenesis (ASD) disorders are a major cause of vision
impairment and blindness. They include developmental ocular deficiencies of the iris, cornea and lens
in addition to significant predisposition, ~50%, to glaucoma. From various studies in recent years it
has become clear that many congenital disorders and predispositions arise from early developmental
defects, both major and subtle. Examining the developmental process giving rise to these essential
components of the visual system is therefore a fruitful approach to studying the disease. The anterior
segment derives largely from the early migrating neural crest cells that target specifically to the
anterior of the developing retina and are loosely classified as periocular mesenchyme (POM). POM
deficiency has been demonstrated in certain cases of ASD. I believe a major roadblock in efforts to
treat and understand ASD has been the limited examination of POM biology and function during early
ocular development. This hampers efforts to characterize the etiology of disease and screening in
ASD families, in addition to delaying attempts at iPSC-­mediated approaches for treatment of ASD. To
circumvent these problems, we aim to comprehensively characterize POM cell specification,
migration, targeting, differentiation, and ultimately contribution to anterior segment dysgenesis. This is
the next logical and necessary step in order for the field to continue the evolution of therapy and
screening for glaucoma and ASD disorders. Our immediate goal is to test the hypothesis that POM
cells delineate into various subpopulations and specify to become the anterior segment
mesenchyme (ASM). To test our hypothesis we propose to employ the highly versatile zebrafish
embryo model system and comprehensively examine POM cell development while cataloging their
contribution to the anterior segment through genetic, molecular and cutting edge in vivo imaging
approaches. Our specific aims are: Aim 1: Characterize specification and define the composition of
the ASM the using a combination of gene expression analysis paired with light-­sheet in vivo time
lapse imaging and confocal microscopy. Aim 2: Track the migratory behavior and lineage trace
distinct populations of ASM during anterior segment formation using light-­sheet in vivo time lapse
imaging and confocal microscopy paired with a novel fate mapping optogenetic tracing mechanism.
Aim 3: Generate a comprehensive ASM transcriptome for screening novel targets in ASD patient
samples using a combination of flow cytometry coupled to RNAseq and next generation exome
sequencing.

Public health relevance
PROJECT NARRATIVE/RELEVANCE TO HUMAN HEALTH: Anterior segment dysgenesis (ASD) disorders have developmental underpinnings that are crucial to our comprehension of vision, disease and advancement of therapy. Clinical practice will directly benefit from studies of animal models like zebrafish, which provides tremendous research advantages including ex utero development, optical transparency throughout development and capacity for genome engineering and disease modeling. The goal of our proposal is to generate the first comprehensive classification of periocular mesenchyme cells in order to facilitate efforts in screening for ASD predisposition and enable future in vivo stem cell therapy.